Actin filament mechanics and branched network turnover

SUMMARY
The assembly of actin filaments into Arp2/3 complex-branched filament networks powers numerous
fundamental eukaryotic cellular processes, including motility, endocytosis, and cytokinesis. Reorganization and
disassembly of these branched networks recycle actin and regulatory protein components, permitting continual
force production and sustained motility. This MIRA proposal integrates biochemical and biophysical
experiments and theory to develop predictive models of actin filament and network mechanics, assembly,
remodeling, and recycling. Completing the proposed research will fill missing gaps in knowledge of the Arp2/3
complex debranching mechanism, specifically how it is regulated by bound nucleotide and force, how
regulatory proteins modulate Arp2/3 complex activity, and the significance of actin isoforms. The proposed
research will also determine how the kinetic properties of an RNA helicase motor protein essential for nuclear
mRNA export and a purinergic signaling enzyme involved in calcification have adapted to fulfill their
physiological roles.

Public health relevance
Narrative Polymerization of the protein actin into helical filaments and branched filament networks powers the directed motility of eukaryotic cells and some pathogenic bacteria. The proposed studies will determine how these filament networks change with time, respond to mechanical forces, and how their molecular components recycle. Kinetic studies on RNA helicases involved in nuclear mRNA export and purinergic signaling enzymes involved in calcification will reveal how these enzymes have adapted to fulfill their specific physiological roles.